Xavier RCMI Renewal Application-Investigator Development Core

Summary of Investigator Development Core
The RCMI Cancer Research Center at Xavier University will establish an Investigator Development Core (IDC)
that will focus on enhancing the health disparities and biomedical research capacity of early career faculty.
The IDC will achieve this goal by providing pilot projects and as well as early career/research development
activities including the matching of investigators with collaborators and mentors. These activities may start
before new faculty begin their responsibilities at Xavier, will continue throughout pilot project research and then
continue as investigators move forward to become research competitive. To accomplish these goals, the IDC
will achieve the following two specific aims: Aim 1. To coordinate and implement training and mentoring
activities focused on increasing the research competitiveness of early stage investigators, mid-career faculty
and research scientists. Multiple activities will link early stage investigators, mid-career faculty and research
scientists to the resources of the Xavier RCMI program as well as other program resources at Xavier with the
goal of building collaborative research programs that will be competitive for achieving external funding. A
focus will be made to develop minority faculty. Accomplishment of this aim will result in more early stage
investigators at Xavier participating in mentored collaborations involving established researchers, more high-
quality publications, more competitive applications for external grant funding and ultimately more research
awards, particularly those addressing health disparities issues. Aim 2. To establish a pilot project program
focused on early career investigators working in collaboration with an established mentor and/or collaborator to
develop research capacity and competitiveness by generating preliminary data for subsequent external grant
applications. The goal of this program is to support early stage investigators at Xavier to generate preliminary
data for submission of grant applications, particularly those that focus on research related to diseases that
disproportionately impact minority or other disparity populations, or that address health disparities.
Involvement of minority faculty will be emphasized and encouraged. This program will involve competitive pilot
funding for up to three years of support and include mentors/collaborators as active participants in the pilot
research as well as the resulting publications and external grant applications. The accomplishment of this aim
will result in more early stage Xavier faculty obtaining high quality and significant preliminary data that will be
incorporated into competitive external grant applications.